Sex-Specific Roles of L-PK in Cholesterol Metabolism and Atherosclerosis

ABSTRACT
Liver is the major hub that is responsible for regulating both plasma cholesterol and triglyceride levels as it is
involved in their synthesis, secretion, and clearance. Several studies have reported that any errors in these
processes will lead to metabolic diseases such as non-alcoholic fatty liver disease and hypercholesterolemia.
Hypercholesterolemia will eventually result in atherosclerosis that is the leading cause of death in US. Also,
plasma cholesterol and triglyceride levels are highly heritable and several human genome-wide association
studies have identified hundreds of genetic loci that could control the levels of these plasma lipids. Unfortunately,
only a small number of these loci have been translated into a gene target and validated through experimental
studies. Therefore, there is a critical need for identifying and validating novel biologically causal candidate genes
that could serve as a therapeutic target. To this end, we used an integrative genomics approach in a panel of
diverse inbred strains of mice to integrate information on natural genetic variations (genomics) with molecular
phenotypes (transcriptomics) and clinical phenotypes (phenomics) and identified a liver gene, liver pyruvate
kinase (L-PK), in regulating hepatic steatosis via mitochondrial involvement. When L-PK was downregulated,
both insulin sensitivity and liver triglyceride levels improved, while L-PK overexpression overloaded the
mitochondrial function, augmenting the disease condition. More importantly, all these observations were made
in male but not female mice. Serendipitously, we also reported that L-PK was associated with regulating plasma
cholesterol levels. Over the next five years, we aim to mechanistically dissect this relationship and their
underlying pathways in a sex-specific manner. The studies proposed in this application aim to address this by
using a combination of an array of experimental approaches including gonadectomy, lipidomic, metabolomic,
transcriptomic and bioenergetic studies, and a novel humanized hyperlipidemia-induced atherosclerosis animal
model. We propose to determine which of the cellular mechanisms (cholesterol synthesis, secretion, and
clearance) are altered by L-PK in altering plasma cholesterol levels and finally, test the hypothesis that L-PK
regulates hyperlipidemia-induced atherosclerosis in a sex-specific manner (Aim 1), and determine the sex-
specific signaling pathways (AR and PTEN-PI3K-AKT signaling) altered by L-PK in mediating this phenomenon
(Aim 2). Upon completion of this grant, we will be able to define how L-PK reprograms cholesterol metabolism,
thereby influencing atherosclerosis progression in a sex-specific manner. Ultimately, this information will aid in
identifying personalized therapeutic implications of L-PK in hypercholesterolemia.

Public health relevance
PROJECT NARRATIVE One of the major complications of hypercholesterolemia is atherosclerosis, which is the leading cause of death in the US. Using a panel of diverse inbred mouse strains, we have recently uncovered a novel sex-specific role for a liver gene, L-PK, in regulating mitochondrial functions and liver triglyceride accumulation, while also suggesting a possible role in regulating plasma cholesterol levels. This R01 proposal aims to address a major public health problem and will define the sex-specific mechanisms by which L-PK regulates cholesterol metabolism and its implications with regards to atherosclerosis progression using state-of-the-art experimental approaches and a team of experts.